Assessing the roles of viral mutations and host factors in the transmission of Mayaro virus and other alphaviruses by urban mosquitoes

Project Summary/Abstract
Alphaviruses are human pathogens that represent a global health threat. Mayaro virus (MAYV) and chikungunya
virus (CHIKV) are alphaviruses that can cause acute disease with fever, headache, myalgia, chills, and long-
term debilitating arthralgia. Adaptation of CHIKV lineages to the urban mosquitoes Aedes aegypti and Aedes
albopictus has contributed to its worldwide distribution and led to large outbreaks. MAYV is thought to be
restricted to transmission by sylvatic mosquitoes of the genus Haemagogus, but laboratory studies show that
MAYV can also be transmitted by Aedes mosquitoes, suggesting the need for improved surveillance and
countermeasures. I found that MAYV can infect Aedes mosquitoes from Salvador (Brazil) or Galveston when
present at titers found in viremia in humans. This project aims to understand how adaptive mutations and
interactions with hosts may lead to the emergence of alphaviruses outbreaks. My central hypothesis is that
mutations in the MAYV nsP3 gene can lead to efficient transmission by Aedes mosquitoes through promoting
viral-host interactions. I will address this hypothesis through three specific aims. In specific aim 1, I will determine
existing and prospective mutations in the genome of MAYV that function in vector competence of Aedes
mosquitoes. I have performed next generation sequencing of salivary glands of infected Aedes mosquitoes and
found 17 putatively adaptive mutations. I will find and validate MAYV minority variants that arise upon mosquito
infection using competition assays, 50% oral infectious dose experiments and dual host models. As a proof-of-
principle, I discovered an adaptive mutation in the virus non-structural protein 3 (nsP3). I will then determine at
which step of mosquito infection they are important through a series of dissections followed by titrations. In
specific aim 2, I will uncover the roles of nsP3 in mosquito infections and vector competence. I will assemble
nsP3 chimeras of different MAYV strains to identify regions that are necessary and sufficient for increased fitness
in Aedes mosquitoes and study a natural insertion that has evolved at least twice in MAYV strains, suggesting it
is adaptive, and its proposed changes in protein phosphorylation. In specific aim 3, I will assess how m6A
modifications on MAYV and CHIKV RNA may promote immune evasion and how these modifications in cellular
RNAs modulate the immune system. These modifications are thought to have key functions in immune system
regulation and immune evasion. I showed that MAYV has m6A modifications on its RNA which are concentrated
in the sub genomic RNA and promote viral replication. Completion of this project will have a major impact in the
control of alphaviruses by spurring novel surveillance strategies and countermeasures targeting virus-host
interactions. This project and career development award aligns well with my current skills and career goals to
become an independent principal investigator. It will help me fill gaps in my knowledge of vectors and to develop
key administrative and writing skills required to become an independent researcher.

Public health relevance
PROJECT NARRATIVE Mayaro and chikungunya are alphaviruses that cause Mayaro fever and chikungunya fever, respectively; they present with fever, headache, muscle pain, chills, and long-term debilitating joint pain. These viruses are transmitted by mosquitoes, and adaptation to urban mosquitoes allows them to cause large outbreaks. Understanding how these viruses adapt to urban mosquitoes is essential for improved surveillance of variants and studies of how these viruses interact with host factors will spur the development of countermeasures against Mayaro and chikungunya viruses.